Clinical Biorepository Core

ABSTRACT
The overall premise of this PPG application is that there are shared biologic pathways in the development of
COPD and IPF. To further understand the epidemiologic, biologic, and genetic characteristics of COPD and
IPF (divergent pulmonary response to common noxious exposures such as tobacco smoke) we are proposing
to aggregate and curate data from several existing COPD and IPF cohorts as well as create a de-novo bron-
choscopy cohort. This Clinical Biorepository Core will provide a harmonized standard dataset for all co-
investigators in this application. These data will include clinical, epidemiologic, physiologic and radiologic sub-
typing information as well as biospecimens which will be used for cross sectional and longitudinal analyses.
To achieve these goals, the Clinical Biorepository Core has brought together an internationally recognized
team of investigators whose expertise spans clinical investigation, radiologic assessments and bronchoscopic
studies. The existing cohorts to be leveraged by this investigation include three NIH funded projects,
COPDGene, SPIROMICS and the Lung Tissue Research Consortium (LTRC), each of which has a wealth of
phenotypic data that will be leveraged for disease subtyping. This Core will also leverage a foundation funded
effort called the Pulmonary Fibrosis Foundation Clinical Care Registry and Biorepository (PFF). Finally, the
prospective Bronchoscopy Population will include 40 ex-smoking subjects with COPD (20 with emphysema
predominant and 20 with airway predominant disease), 30 ex-smokers with IPF (15 with Typical UIP and 15
with probable/inconsistent UIP) and 20 age and sex matched controls (all ex-smokers).